Asymmetric Single-Chain MspA nanopores for electroosmotic stretching and sequencing proteins

Project Summary / Abstract
Protein identification and/or single-molecule protein sequencing from minute amounts could revolutionize our
understanding of health by providing a picture of the molecular state of the cell at the level of its most
functional molecules. Through this multi-PI proposal, we will develop prototype tools that employ innovative
protein-based nanopores for probing the sequence of individual protein molecules. The protein sequencing tool
is based on engineered MspA, a porin from Mycobacterium smegmatis that has been utilized in nanopore-
based DNA sequencing. However, our protein detection/sequencing tool will be engineered in the following
ways: 1) Each of the protein monomers that comprise the octameric assembly are covalently connected,
enabling mutagenesis along this single-chain MspA (scMspA) protein to create a series of mutants with
asymmetric constrictions as high-resolution nanopores for reading amino acid sequences (recently
demonstrated by Niederweis and Wanunu groups), 2) A DNA-processing enzyme will be used to move short
peptides and full-length proteins through the pore by conjugation of these peptides to DNA and ATP-mediated
DNA translocation, 3) the full compatibility of our system with denaturing electrolyte conditions during pore
experiments will facilitate three critical requirements for high accuracy peptide/protein readout in a sequence-
independent manner - protein unfolding, protein threading, and a driving force to stretch the protein so it is
pulled taut at the pore (all of these recently demonstrated by Wanunu, Aksimentiev, and Chen groups). These
combined innovations, combined with key technological capabilities of the team, will allow us to develop a
protein sequencing prototype. We propose to achieve our goals through research in three main aims: 1) We
will engineer and test various asymmetric scMspA mutants to optimize signal contrast from similar protein
sequences with single amino acid substitutions, 2) we will demonstrate helicase-mediated motion of peptide
libraries through scMspA mutants and signal decoding, and 3) we will read subsets of full-length unfolded
proteins in a complex sample that contains many proteins, and train a model to recognize this sets based on
pure protein samples. For the most promising mutant scMspA we will target >90% accuracy in distinguishing
among all peptides/proteins in the sample set. Success in our developed platform will result in adoption and
product development in order to revolutionize single-molecule and single-cell proteomics.

Public health relevance
Project Narrative We propose to develop an automated single-molecule protein scanner, based on a unique class of engineered nanopores that have asymmetric internal structures optimized for high-resolution discrimination of amino acid sequence. The protein scanners will identify the protein type and is likely to pick up on small changes in the sequence of amino acids in proteins. Success in our proposed aims would serve as a major steppingstone towards single-molecule proteomics, where individual proteins in a mixture extracted from cells or biofluids are sampled and analyzed to reveal their identities and quantify them.